PATHOPHYSIOLOGY OF ENDOTOXIN-MEDIATED FEVER

DESCRIPTION: (Applicant's abstract) Fever is the hallmark of infection. It is generally believed that it is caused not by exogenous, but by endogenous pyrogens, members of an array of peptide mediators called cytokines. These are elaborated and released into the circulation largely by systemic mononuclear phagocytes activated by the exogenous agents, and transported to the preoptic anterior hypothalamic area (POA) of the brain, where they act. Prostaglandin E2 (PGE2) is thought to be a fever mediator in the POA, induced by these cytokines. Although the intrapreoptic level of PGE2 rises rapidly following the intravenous (iv) administration of exogenous (e.g., lipopolysaccharides, LPS) or endogenous pyrogens, recent data indicate that these substances cannot account directly for the rapid production of PGE2 because it is initiated well before the synthase that they stimulate (cyclooxygenase-2, COX-2) becomes active. Moreover, cytokines also are not detectable in blood following iv LPS until after the febrile response is already underway, and there is no evidence that they can readily penetrate the brain. Hence, other, more quickly evoked mediators may be presumed to be involved in initiating the febrile response. Based on well-recognized mechanisms of LPS action and on new data regarding the induction of PGE2 synthesis, we have hypothesized that 1) iv LPS virtually immediately activates the complement cascade, generating the anaphylatoxins C3a, C4a, and C5a, which 2) function to rapidly induce various mediators, e.g., platelet-activating factor (PAF), bradykinin (BK), that 3) have the capacity to stimulate the formation of nitric oxide (NO) which, in turn, 4) induces PGE2 and, consequently, fever. We have preliminary evidence supporting the involvement of systemic complement and of nitric oxide in the organum vasculosum laminae terminalis (OVLT, the interface between the brain and circulating pyrogens) in the febrile response to iv LPS. The purpose of this proposed research is to substantiate the putative roles of complement and NO in the pyrogenic response to iv LPS, and to determine whether PAF and/or BK are factors that may link the two. If confirmed, this hypothesis would allow formulating a novel, specific concept of the pathophysiology of LPS-mediated fever, particularly regarding the onset of this response. The results will be relevant to the still essentially unknown central nervous mechanisms underlying the multivariate host defense reactions to infectious pathogens.